HEDGEHOG SIGNALING IN CARDIAC SEPTATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The aim of the project is to understand etiology of cardiac septation defects present in anterior heart field specific knockout of smoothened mouse embryos using specimens on the 9T MR magnet.